An Intersectional Approach to Gender Affirmation in Sex and Gender Reporting among Racial/Ethnically Diverse Trans Populations

PROJECT SUMMARY
Ongoing research to improve assessment of sex and gender among transgender participants remains a key
priority. In order to ensure research on transgender health is effective, impactful, and valid, meaningful and
affirming measurement of gender and sex characteristics is essential. Current recommendations emphasize
use of a two-step method which asks for individuals' sex assigned at birth and current gender identity.
However, two-step methods which have been tested remain poorly attuned to intersex experiences and
experiences of non-binary gender identity. In addition, alternative two-step methods, three-step methods,
choose-all-that-apply methods, and open-response methods have all been proposed as alternatives in recent
years. As a result, it is imperative that current two-step methods are effectively refined and receive appropriate
comparative testing relative to other proposed methods. Moreover, gendered experience is contextual; cultural,
temporal, and other forms of gender diversity are not captured by many two-step methods currently in use.
Tailoring our methods to improve validity for transgender and gender-diverse individuals who do not fit the
normative, binary experience of gender in the United States is therefore essential. Finally, while questions of
measure validity are critical to this work, it is also important to consider the ways in which transgender and
gender diverse individuals experience the act of reporting sex and gender on survey questions itself, and in
particular, the ways in which measures of sex and/or gender may be experienced as stigmatizing or affirming
by transgender and gender diverse respondents. Stressors related to discrimination and victimization tied to
SGM status are strongly associated with health disparities, whereas multilevel experiences of affirmation are
known to promote transgender health on the individual and population levels. Therefore, we must consider that
measures of sex and gender which reinforce normative conceptualizations of these constructs have the
potential to act as microaggressive minority stressors, and to contribute negatively to the health of transgender
and other gender diverse respondents. This project, a supplement to an existing, mixed-methods study aimed
at improving measurement of sex, sexual orientation, and gender identity (SSOGI) through community-
engaged methodologies, addresses both the current gaps in the literature regarding the validity of two-step and
alternative measures of sex and gender, and advances a new line of inquiry which centers the importance of
trans affirmation in research. In addition, drawing on the theory and methodology of intersectionality, this
project will advance understanding of how best to measure and respond to health inequities for transgender
and other gender diverse communities of color. Through qualitative and quantitative testing, we will better
validate existing measures of sex and gender in more diverse populations, and develop new lines of inquiry
which can be used to strengthen transgender health research moving forward.

Public health relevance
PROJECT NARRATIVE The report of the National Academies of Science, Engineering, and Medicine (NASEM) on Measuring Sex, Gender Identity, and Sexual Orientation for the National Institutes of Health (NIH) emphasized the importance of ongoing research regarding how best to measures sex and gender for transgender populations; the report in particular emphasizes the importance of research which centers transgender and gender diverse populations of color. In response to this gap in the science, this project proposes a supplement to an existing, community- engaged mixed-methods R01 grant focused on improving measurement of sex, sexual orientation, and gender identity (SSOGI); using a pool of recommended measures of sex and gender identified through the parent grant, this supplement draws on the methodological and theoretical traditions of intersectionality to explore the contextual validity and respondent experiences of a variety of endorsed methodologies including two-step, open-ended, and choose-all-that-apply methods, among others, among racially and ethnically diverse transgender and gender diverse individuals. Moreover, we will for the first time consider how measures of sex and gender may themselves be experienced as either harmful minority stressors or affirming by transgender and gender diverse respondents, and consider the impact these experiences themselves have on transgender health; our approach centers the lived experiences and perspectives of transgender and gender diverse individuals in order to develop recommendations attuned to questions of both meaningful data, and affirming experience for transgender health research.